Biostatistics and Bioinformatics Core (Core C)

SUMMARY: BIOSTATISTICS AND BIOINFORMATICS CORE (CORE C)
The Biostatistics/Bioinformatics Core for MD Anderson Cancer Center SPORE in Brain Cancer is a
comprehensive, multilateral resource for the design of basic science experiments and clinical trials, and
appropriate statistical analysis of the resulting data. The Biostatistics and Bioinformatics Core incorporates sound
experimental design principles that enhance interpretability of study results, performs data analyses using
appropriate methodology, and contributes to interpretation of results through written reports and frequent
interaction with project investigators. Thus, from inception to reporting, translational experiments benefit from
SPORE resources which are used to augment existing M.D. Anderson Cancer Center Biostatistics and
Bioinformatics resources. The Biostatistics and Bioinformatics Core collaborates with all project investigators to
facilitate the timely publication of all data collected under the Brain Cancer SPORE program.
To serve all proposed SPORE Projects, as well as the Career Enhancement and Developmental Research
Programs, the Biostatistics/Bioinformatics Core has the following objectives:
• Provide biostatistics and bioinformatics expertise in the design and conduct of laboratory experiments and
clinical trials arising from the research proposed in this application,
• Provide biostatistics and bioinformatics analysis and interpretation of all data collected under the SPORE
Projects, Developmental Projects, and other Cores, and
• Collaborate and assist all project investigators with the publication of scientific results.

Public health relevance
NARRATIVE: BIOSTATISTICS AND BIOINFORMATICS CORE (CORE C) Appropriate statistical analysis of the data resulting from translational research and the publication of the information is critical to the advancement and distribution of scientific information, through which the outcome of patients with malignant gliomas will be improved.